Molecular genetic mechanisms of opioid receptor signaling

Summary
Opioid drugs are the most widely used analgesics in the clinic, and are also some of the most widely abused
substances. The adverse actions of these drugs, including peripheral side effects, dependence and tolerance,
severely limit their utility for long term pain management. The -opioid receptor (MOR) is the primary target of
the analgesic and rewarding effects of opioids. Thus, efforts aimed at developing safer and more effective
opioid treatments will require a much deeper understanding of MOR signaling.
Our long-term goal is to use unbiased forward genetics to dissect the molecular organization of the
MOR signaling network using whole-animal behavioral responses to opioids as a phenotypic readout.
Towards this goal, we developed a transgenic MOR model (tgMOR), in which mammalian MOR is expressed
in the nervous system of the nematode C. elegans. We found that tgMOR animals gain the ability to respond to
opioids, and exhibit all the cardinal behavioral hallmarks of opioid responses seen in higher organisms
including acute depressant effects, desensitization and tolerance. We further demonstrated key known
molecular players that control opioid responsiveness in mammals play conserved functions in tgMOR worms.
Using this novel tgMOR model, we have completed an unbiased, forward genetic screen for modifiers of
behavioral opioid sensitivity, and isolated a large number of mutants with altered opioid responses. We have
developed a pipeline for discovery, identification and validation of genes responsible for phenotypes using a
combination of whole genome sequencing, mapping and targeted CRISPR/Cas9 gene editing. Using this
approach, we uncovered several known and novel genes that regulate opioid responsiveness in worms, and
confirmed their effects on MOR signaling using cell-based assays with cultured mammalian cells.
Our findings suggest an elaborate, largely unknown, network of players exists to regulate MOR
signaling. Thus, the main effort of this project focuses on identifying and characterizing these players by
analyzing tgMOR mutants isolated from our unbiased, forward genetic screen. Our first aim will be to identify
the genes responsible for 1) hypersensitivity, 2) hyposensitivity, and 3) impaired tolerance to opioid drugs by
pursuing a subset of mutants from each phenotypic category. In the second aim, we will validate and perform
mechanistic studies on identified, conserved regulators of MOR signaling using a comprehensive platform of
cell-based assays that monitor various aspects of MOR signaling. The third aim will focus on exploring the
pharmacogenomics by which MOR impacts behavior. To do so, we analyze interactions between genetic MOR
variants found naturally in the human population, FDA-approved opioid drugs, and different genetic
backgrounds using a humanized tgMOR C. elegans platform. It is anticipated that these studies will advance
our understanding of how opioids act thereby paving the way for the development of safer opioid therapeutics.

Public health relevance
Project Narrative More than 76 million Americans use opioid drugs as analgesics for the treatment of long-term pain, and more than 2 million Americans now have opioid use disorders. This research program will identify and evaluate molecular mechanisms intimately linked to treatment of chronic pain and addiction. Thus, this project has long-term potential to contribute significantly to managing two major problems in medicine.